Solvation modeling for next-gen biomolecule simulations

Apparatus ForteBio/Sartorius OCTET R2 for biolayer interferometry.
Bio-Layer Interferometry is an analytical technique that monitors the interference pattern of
white light reflected from two surfaces; a layer of immobilized protein on the biosensor tip
and an internal reference layer. The binding of an analyte in solution to the immobilized
protein (ligand) on the biosensor results in an increase in optical thickness which in turn
causes a shift in the interference pattern resulting in a wavelength shift. From this wavelength
shift the apparatus enables real-time determination of kinetics, protein-ligand affinity and
antibody/protein quantitation without the need for fluorescent labeling.
Approximate price including taxes is 204,000 USD.

Public health relevance
The Apparatus ForteBio/Sartorius OCTET R2 for bio-Layer Interferometry monitors the interference pattern of white light reflected from two surfaces, a layer of immobilized protein on the biosensor tip and an internal reference layer, from which the strength of ligand binding to the protein can be determined. The binding of an analyte in solution to the immobilized protein (ligand) on the biosensor results in an increase in optical thickness which in turn causes a shift in the interference pattern resulting in a wavelength shift. From thiexcs wavelength shift the apparatus enables real-time determination of kinetics, protein-ligand affinity and antibody/protein quantitation without the need for fluorescent labeling. Within the project we study the influence of excipients on the stability and aggregation properties of the protein solutions. The direct determination of the ligand binding strength using biolayer interferometry is relatively new, and the purchase of this apparatus would enhance the user access to this new technology.